CLINICAL TRIAL: ORAL INSULIN FOR PREVENTION OF DIABETES IN PATIENTS AT RISK FOR

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a trial of oral insulin administration to see if it will prevent development of Type 1 diabetes in subjects who are determiined to be "at risk" based on lab work.